ADMINISTRATIVE CORE

The administrative core will serve to facilitate communication between the three projects and the cores. This will be accomplished by arranging for teleconference calls as needed. The projects also propose to hold live videoconferences as often as needed to facilitate data sharing and analysis and it will be the responsibility of the administrative core to arrange these. An FTP site has been established at Brown so members of each team can upload large data files for analysis. The administrative core will track and analyze expenditures submitted to Brown from the Pis of projects #1 and #3 and from core B. Ms Tammy Glass has experience in these activities as she currently manages a multi-component COBRE account for Dr. Atwood, Invoices will be reviewed monthly by Dr. Atwood and by Ms Glass and when approved will be sent to accounts payable for immediate payment. The administrative core will assist in the preparation of annual progress reports. This will be done yearly well in advance of the deadlines for submitting progress reports. Ms. Glass will be responsible for collating these reports electronically and forwarding them to the appropriate awarding institute.

Public health relevance
An administrative core is essential to the operation of the program.